Administrative Core

Core A Summary Abstract
The purpose of the Administrative Core is to oversee the administrative responsibilities of the various laboratory
studies outlined in the Projects 1, 2 and 3 in this P01. The Administrative Core will provide high-level
organizational support for the Projects, including provision of necessary resources, fiscal oversight, adherence
to institutional and NIH guidelines/regulations. The Administrative Core will further coordinate regular joint
meetings to disseminate results, discuss scientific challenges, and discover innovative solutions to advance the
science. The Administrative Core will serve to integrate scientific efforts for sample collection and clinical factor
analysis within and between Projects through the (i) coordination of sample tracking and (ii) the retrieval and
data collection for all 3 Projects with institutions both within and outside of DFCI. The Administrative Core also
has responsibility for the submission/maintenance of regulatory documents related to samples. The
Administrative Core will further promote the rapid dissemination of significant research findings to the scientific
community. These activities will serve to enhance the integration of the rich scientific efforts within and between
Projects, and foster the translation of findings to the patient care setting; and conversely, the initiation of
laboratory studies stemming from clinical observations and tissue samples obtained in all 3 projects. Altogether,
this central resource for the Projects will enhance interactions among the investigative teams to further the
translational goals and vision of this Program for integrating genomic, functional and clinical information of
patients with Richter's Syndrome.

Public health relevance
Core A Project Narrative The Administrative Core will oversee the administrative responsibilities of the various laboratory studies outlined in the three Projects, by providing high-level organizational support for the Projects. These include provision of necessary resources, fiscal oversight, adherence to institutional and NIH guidelines/regulations, and the coordination of regular joint meetings to disseminate results, discuss scientific challenges, and discover innovative solutions to advance the science. The Administrative Core will further promote the rapid dissemination of significant research findings to the scientific community.